MOLECULAR MECHANISMS CONTROLLING IGE LEVELS IN ALLERGIC PATIENTS

We hypothesize that we can determine alteration in the molecular regulation of IgE in some individuals which are induced by disease and resolved by therapy.